Induction of Protective Immune Responses Against C. neoformans in Immune Compromised Hosts

Cryptococcus neoformans infections are a significant cause of morbidity and mortality among AIDS patients.
Cryptococcal meningoencephalitis is the most common disseminated fungal disease in AIDS patients and is
responsible for 15% of AIDS-related deaths globally. Because host immune responses are so vital to the
control of cryptococcosis, the overall objective of our laboratory is to determine the mechanism(s) necessary to
elicit protective immunity against C. neoformans infections in immune deficient hosts. To this end, studies in
our laboratory employ a C. neoformans strain engineered to express interferon (IFN)-, designated H99, as a
model system to define protective immune responses against C. neoformans. Published studies by our lab
demonstrated that immunization with H99 induces protective immunity against cryptococcosis in mice
altogether deficient in B cells, CD4+ T cells, CD8+ T cells, NK cells and neutrophils. Preliminary results provided
herein suggest that conventional DC1 cells (cDC1s) are critical for the development of macrophage anti-
microbial activity, optimal T cell responses and the induction of protective immunity against cryptococcosis.
Taken together, our results lead us to hypothesize that cDC1s are critical for the elicitation of protective
vaccine-mediated immune responses against cryptococcosis in CD4+ T cell deficient hosts. The
foundation for our hypothesis is supported by a scientifically rigorous set of published and preliminary results
that demonstrate the potential impact of strategies that prime cDC1s to elicit protective immunity against
cryptococcosis in immune deficient hosts. To test our hypothesis, we propose to define the mechanism(s) by
which IFN- primed cDC1s mediate protective anti-Cryptococcus immune responses in immune compromised
hosts.

Public health relevance
The studies proposed in this application will facilitate a determination of the mechanisms necessary for inducing protective immune responses against cryptococcosis; a disease that is responsible for significant morbidity and mortality among AIDS patients and other immune compromised individuals.